The complex interaction between Alzheimer drivers and aging

The complex interaction between Alzheimer drivers and aging
Project Summary/Abstract (30 lines of text)
The greatest risk for Alzheimer’s disease is age. This extremely tight correlation with age has
no explanation. However, most of what know about Alzheimer’s comes from early onset cases.
We will utilize the 100 cases of early onset AD stored in the Colombian brain bank all with the
same PSEN1[E280A] mutation to determine the full range of pathology observed due to a
monogenic defect and compare these data to sporadic older onset disease. Some of the
Colombian individuals in the bank have had amyloid and tau PET studies. In sporadic disease
among the elderly, brain changes related to aging are frequent and in the absence of their
clear delineation, treatments targeted solely at dominant genetic forms of the disease may be
ineffective. Factors which might distinguish and promote AD in the elderly include inflammation,
compromised brain vasculature, excessive microgliosis, cellular aging such as break down of
the nuclear membrane and consequently escape of TDP-43 from the nucleus and possible
contributions of synuclein. We will explore interactions of these factors with aging through
descriptive neuropathology and experimental neuropathology methods. Comparisons will utilize
sporadic AD post-mortem from several brain banks. These studies include state of the art
single cell RNAseq and advanced assessment of inflammation markers. Cellular models will be
explored using human induced pluripotent stem cell-derived neurons that harbor the
PSEN1[E280A] mutation and are intended to discover downstream pathways affected by the
mutation. Co-cultures with microglia to capture autonomous and non-autonomous effects of the
mutation will be determined.
To accomplish the aims we have assembled a multi-institutional international team with a long
history of collaboration. Dr. Lopera, who first recognized the families and manages the
Alzheimer Prevention Trial, heads the team in Colombia, an NIH supported project. To support
the neuropathology effort we have enlisted the expertise of Dr. Eric Huang. Kosik has a nearly
30 year collaboration with Lopera, is familiar with the conduct of research in Colombia and
recently traveled to visit the Colombian brain bank with Eric Huang. Kosik is closely connected
institutionally with UCSF through his role as co-director of the Tau Consortium along with Bruce
Miller. Kosik has published with Ellisman and serves on the review board for the National
Center for Microscopy and Imaging Research center at UCSD. Thus the project consists of a
strong, experienced and highly integrated team capable of conducting a complex project and
dealing with any of the obstacles that will inevitably arise.

Public health relevance
Project Narrative Aging and Alzheimer’s disease are often inextricably linked; however, in cases with certain mutations the disease onset occurs early and before the changes of advanced age set in. We will compare a very large sample of brains that all harbor the same early onset Alzheimer gene mutation— PSEN1[E280A] to sporadic age-related disease. We propose a complete neuropathological analysis of this invaluable resource and the development of cellular models from living cells with this mutation.